Social Networks and Cognitive Health among Black and Latino sexual minority men in NJ

Project Summary
This proposed study, aligned with RFA-AG-24-025, aims to address how interpersonal processes and social
network characteristics of aging Black and Latino sexual minority men (SMM) facilitate or impede health
behaviors affecting cognitive performance. Little is known about the mechanisms of health behavior change
within social networks over time in aging Black and Latino SMM. Our proposal will address critical gaps in
knowledge that have prevented the development of effective social network interventions to promote social and
physical activities and maintain cognitive health among aging Black and Latino SMM.This will be achieved by
using respondent-driven sampling (RDS) to establish a cohort of 400 aging Black and Latino SMM in Essex,
Bergen, and Hudson counties, New Jersey in order to assess the following specific aims: 1) Cross-sectionally
elucidate the association between interpersonal (intersectional stigma and social support) and social network
characteristics and health behaviors (social and physical activities) among aging Black and Latino SMM; 2)
longitudinally examine interpersonal and social network characteristics (network stability, density, centrality)
that act to promote or impede social and physical activities; and 3) longitudinally examine variability in
interpersonal and social network characteristics and their time-lagged relationships with subsequent trends in
social and physical activities and cognitive performance. Our research will establish critical knowledge that will
improve the understanding of pathways and processes of interpersonal and social network influences on
health behaviors associated with cognitive performance. It will provide important new information for the future
development of strengths-based interventions intended to boost the ability of aging Black and Latino SMM to
leverage protective social network effects.

Public health relevance
PROJECT NARRATIVE Cognitive performance is of key concern among aging populations, but little research has been conducted on cognitive performance among aging Black and Latino sexual minority men (SMM). We will use respondent- driven sampling to recruit a cohort of aging Black and Latino SMM in Northern New Jersey and assess how their social networks are constructed, and how social and physical activities promoted within these social networks and interpersonal processes (intersectional stigma and social support) may be protective for cognitive performance. Our findings will provide valuable data for health providers, public health researchers, and policymakers to more effectively intervene across the complex pathways between marginalized social position, stigma, social networks, and cognitive performance outcomes.